Center for Urban Responses to Environmental Stressors

Situated in the heart of Detroit, the Center for Urban Responses to Environmental Stressors (CURES) aims to
understand and mitigate the adverse health impacts of exposures to a complex array of chemical and non-
chemical stressors in a postindustrial urban environment. CURES recognizes that each urban neighborhood
has a unique combination of geographic (e.g., locale relative to legacy and emerging pollution sources),
historic (e.g., land use, age and condition of housing stock), and demographic (e.g., socioeconomics, race,
ethnicity, age) characteristics that together create the spectrum of environmental risk and environmental justice
issues that produce disparities in the incidence and severity of adverse health outcomes including preterm
birth, cancer, cardiovascular disease, and diabetes. A community-engaged, transdisciplinary team science
approach is essential to address the major environmental health challenges facing Detroit’s racially and
ethnically diverse population. We have assembled a talented interdisciplinary team of established and
emerging environmental health scientists who work with our community partners to accomplish this work. We
listen to our community partners, and their concerns inform the Center and provide direction for building our
research capacity so that our research translates back to the community. CURES advances the NIEHS 2018-
2023 Strategic Plan by performing research that increases environmental health science knowledge, converts
“data to knowledge to action,” and supports the growth of workforce diversity, team-building, and collaboration.
To create a gateway to a healthy urban environment starting with Detroit, CURES’ short-term goals are to 1)
strengthen CURES existing partnerships and develop new ones within the Detroit community, and in
collaboration with our community partners identify environmental threats common to US urban populations and
provide scientifically-based strategies to mitigate them; 2) conduct integrated mechanistic, epidemiological,
and community-engaged research that addresses the consequences of urban chemical and non-chemical
exposures on human health; 3) build CURES’ investigator capabilities by providing facility cores that provide
state-of-the-art analytical services as well as pilot funds to explore the feasibility of new areas of study; 4)
secure the long term contribution of CURES on the discipline of EHS by mentoring new and established
investigators to attain their professional goals and prepare them for EHS leadership; and 5) foster a culture of
antiracism, inclusion, and environmental health equity throughout the Center. Our long-term goal is for CURES
to be a premier Environmental Health Sciences Core Center that is focused on urban environmental health,
environmental justice, and resilience in the face of chemical and non-chemical stressors. CURES is optimally
positioned to pursue innovative, community-engaged, team science research opportunities that have the
greatest promise to deliver transformative gains in the early detection, prevention, and eventual eradication of
urban environmental disease in our lifetime.

Public health relevance
The Wayne State University "Center for Urban Responses to Environmental Stressors (CURES)” strives to establish a cleaner and healthier living and working environment in the City of Detroit and other urban areas. A preponderance of our citizens disproportionately suffer the consequences of systemic racism, poverty, and environmental health disparities. CURES applies integrative teamwork, community-engaged research, and the latest technologies to understand how exposure to urban environmental chemical and non-chemical stressors affects human health. CURES seeks smart solutions that will reduce and ultimately eliminate the negative impact of these stressors.